The pathogenic roles of GSDMD-dependent gut epithelium extracellular vesicles in IBD

Abstract
Understanding how environmental factors trigger dysregulated immune responses was identified as a key challenge in preclinical research for the pathogenesis of inflammatory bowel disease (IBD). Dysregulated responses to the luminal environment by intestinal epithelial cells (IECs) have been widely postulated to be a driver of IBD. On the other hand, the success of immunomodulatory biologics, such as vedolizumab and ustekinumab, clearly demonstrate the central role of T cells, especially pathogenic T cells, in IBD. However, it remains unclear how IECs convey innate immune detection at mucosal surfaces to adaptive immune responses and subsequent inflammation. Emerging at the center of this sensing function is the inflammasome, which can detect cellular stress and danger signals, such as ATP, found in injured tissues during chronic inflammation. In our quest to understand the role of the inflammasome in IECs, we found that IECs release large amounts of small extracellular vesicles (sEVs) containing polyubiquitinated IL-1 family cytokines, including IL-1 and IL-18, in response to inflammasome activation in a GSDMD-dependent manner. Importantly, IEC-derived sEVs represent a novel form of communication between IECs and T cells. In particular, IL-18 promotes inflammatory pathogenic T cells via induction of IFNγ and GM-CSF production. sEVs-derived from inflamed mouse colons exacerbate disease and confer resistance to anti-TNF treatment in a T cell transfer colitis model. Consistently, IECs from biopsies of inflamed areas from IBD patients displayed enhanced capacity to produce sEVs compared to that from non-inflamed areas. Thus, we hypothesize that IEC-derived sEVs play a critical role in IBD pathogenesis by amplifying epithelial inflammatory responses and promoting pathogenic T cells via the release of sEVs containing IL-1 family cytokines, including IL-1 and IL-18, and perhaps IL-33. This application seeks to determine the molecular mechanism(s) that underlie the release of sEVs and assess the importance of sEVs in promoting pathogenic T cells and anti-TNF therapy failure in murine models of colitis and in patient-derived specimens from IBD patients.

Public health relevance
Public Health Relevance Inflammatory bowel disease (IBD) affects more than a million people in the United States, alone, and there is presently no cure, with limited preventive measures for this condition. We recently discovered that the inflamed mouse and human colonic epithelium produces extracellular vesicles containing IL-1 family cytokines, including IL-1 and IL-18, that exacerbate T cell-mediated colitis and cause anti-TNF therapy failure. This application aims to provide mechanistic insight into this pathogenic cross-talk between intestinal epithelial cells and T cells, and to identify potential targets to address anti-TNF therapy failure using murine colitis models and clinical specimens from IBD patients.